Epidemiology of Acinetobacter baumannii: An Emerging Nosocomial Pathogen

DESCRIPTION (provided by applicant): This K23 proposal combines focused coursework and training, a thoughtful research plan and an expert mentoring team and is designed to foster the development of Kerri Thom, MD, MS into a successful, independent investigator in the study of emerging infections and antibiotic resistance. Dr. Thom proposes to study the hospital epidemiology of Acinetobacter baumannii. This organism has emerged as an important cause of nosocomial infections due to a rising incidence, associated morbidity and mortality and the rapid development of multidrug resistance. In Aim 1, Dr. Thom will identify Acinetobacter colonization among a large, existing cohort and will use molecular typing to quantify the amount of patient-to-patient transmission in the endemic setting. Aim 3 will also utilize this cohort to examine the association between environmental contamination and subsequent nosocomial transmission. In Aim 2, Dr. Thom will prospectively identify a cohort of patients infected with Acinetobacter to determine the rate of contamination of the surrounding environment and to identify heavily contaminated sites. This research will lead to an improved understanding of the hospital epidemiology of Acinetobacter, including the modes of transmission and the role of the environment in nosocomial spread, which will be essential in the development of cost-effective interventions aimed at decreasing transmission. This K23 award will provide Dr. Thom with the opportunities for specific training in molecular epidemiology, antimicrobial resistance mechanisms and research informatics which will be essential to the success of this proposal and to her future success in patient-oriented research in emerging pathogens and antimicrobial resistance. To help achieve these goals, she has assembled a mentoring team with a wealth of experience: Drs. Harris (emerging pathogens/antibiotic resistance, research informatics), Stine (molecular epidemiology, bioinformatics), Roghmann (emerging pathogens/antibiotic resistance, molecular epidemiology), Magder (biostatistics), Bonomo (antibiotic resistance mechanisms), and Srinivasan (Outbreak investigation of Acinetobacter). The support of this K23 award will provide the experience and training needed to compete for R01 NIH grant funding and will serve as a foundation for a career as an independent investigator and a leader of emerging pathogens and antibiotic resistance.

Public health relevance
PUBLIC HEALTH RELEVANCE: Acinetobacter is an important cause of nosocomial infections and is associated with significant morbidity and mortality. Yet our knowledge about this organism is far less developed then that for other nosocomial pathogens, such as MRSA. Much of what we do know comes from outbreak investigations and knowledge of the modes of transmission and the role of environmental contamination in the endemic setting is lacking. PROJECT NARRATIVE (RELAVENCE STATEMENT) Acinetobacter is an important cause of nosocomial infections and is associated with significant morbidity and mortality. Yet our knowledge about this organism is far less developed then that for other nosocomial pathogens, such as MRSA. Much of what we do know comes from outbreak investigations and knowledge of the modes of transmission and the role of environmental contamination in the endemic setting is lacking. __SpecificAimsTextDelimiter__ Specific Aims In the last decade Acinetobacter has become an increasingly important cause of nosocomial infection due to a rising incidence, associated morbidity and mortality, the development of multi-drug resistance, and its propensity to cause outbreaks. Data from the National Nosocomial Infections Surveillance System show that the proportion of nosocomial pneumonias due to A. baumannii increased from 4% in 1986 to 7% in 2003 (p<0.001); while the proportion of all other Gram-negative pathogens remained the same or decreased 18. Similar findings were demonstrated for urinary tract and surgical site infections. Infection due to A. baumannii results in adverse patient outcomes and has been associated with an attributable mortality as high as 37%19. An important characteristic of Acinetobacter is its unique ability to rapidly develop multidrug-resistance. In fact, isolates are frequently encountered which are resistant to most and sometimes all common antimicrobials, making treatment a challenge. Yet, very few novel antibiotics are being developed for Gram-negative infections, including Acinetobacter, so we can expect this challenge to increase in the future. Despite the clinical importance, knowledge about A. baumannii is far less developed than that for other nosocomial pathogens such as P. aeruginosa and MRSA20. Nosocomial infection with Acinetobacter may result from either endogenous flora or cross transmission between patients (i.e. patient-to-patient transmission) either directly or indirectly via healthcare workers and/or environmental contamination; although the specific contribution of each remains unclear in the endemic setting. Acinetobacter species are ubiquitous and have been cultured from multiple environmental sources in the hospital during outbreak situations. The ability to survive on environmental surfaces for long periods of time suggests that hospital equipment and other surfaces could severe as a unique reservoir for infection. Although environmental contamination is believed to contribute to transmission during some outbreaks, the role of the environment in endemic transmission is not known. Recent reports have suggested the ability of Acinetobacter to develop resistance to disinfectants and biocides used during hospital cleaning21-23. These reports are concerning and suggest that environmental contamination may lead to nosocomial transmission despite current cleaning practices. As outlined in this research proposal, my short-term goals are to: 1) Quantify the importance of patient- to-patient transmission of A. baumannii in the endemic setting; 2) Determine the rate of environmental contamination with A. baumannii and identify the environmental surfaces most commonly contaminated; and 3) Evaluate the efficacy of standard hospital procedures including terminal cleaning to prevent environmental contamination and reduce nosocomial transmission of A. baumannii. Through the research outlined, I will gain a better understanding of the epidemiology, nosocomial transmission and molecular mechanisms of resistance of A. baumannii, which will be essential in the future design and implementation of effective infection control interventions and reducing spread of this organism. In addition, I hope to translate this research involving A. baumannii into a career in the study of emerging pathogens and antimicrobial resistance. Specific Aim 1: To estimate the proportion of A. baumannii acquisition due to patient-to-patient transmission in a retrospective cohort study in an endemic ICU setting Hypothesis 1: Patient-to-patient transmission accounts for the majority of nosocomial A. baumannii. Specific Aim 1- Steps: A. Construct a retrospective cohort of approximately 10,000 adult patients admitted to the medical and surgical ICU at the University of Maryland Medical Center from 2001 to 2008. B. Identify patients who were colonized with A. baumannii at ICU admission and who acquired A. baumannii colonization during their ICU stay using existing peri-rectal surveillance swabs. C. Perform multilocus sequence typing (MLST) and pulsed-field gel electrophoresis (PFGE) on the first 100 isolates and compare the discriminatory power of each typing method. For these first 100 isolates we will also determine the genetic basis of resistance. D. Perform molecular typing using PFGE on A. baumannii isolates among patients colonized on admission to the ICU and among those who became colonized during their ICU stay to determine genetic relatedness. E. Determine the percent of acquisition of A. baumannii isolates that were the result of patient-to-patient transmission using the results of 1D. Specific Aim 2: To estimate the association between patient burden of infection or colonization and contamination of the patient's immediate environment in a prospective cohort of patients with A. baumannii infection or colonization Hypothesis 2: Environmental surfaces in rooms of patients with a "High Burden of Organism" (defined as those patients who have both Clinical Culture Positivity for A. baumannii and two or more positive surveillance cultures indicating colonization) are more likely to be contaminated compared to rooms of patients with a "Low Burden of Organism" (defined as those patients who have Clinical Culture Positivity for A. baumannii and either 0 or 1 positive surveillance cultures). Specific Aims 2 - Steps: A. Prospectively identify approximately 128 adult patients admitted to the medical and surgical ICU over a two-year study period who have a positive clinical culture for A. baumannii (i.e. "Clinical Culture Positivity"). B. For each person identified above, after obtaining informed consent, collect peri-rectal, respiratory, wound and skin surveillance cultures to determine the degree of Colonization with A. baumannii. C. Perform environmental cultures of patient's room at enrollment into the study to determine the prevalence of environmental contamination with A. baumannii at baseline. D. In a sub-set of rooms, decontaminate the environment using standardized cleaning after patients have been identified (Aim 2A) and baseline environmental cultures have been performed (Aim 2C), followed by repeat environmental sampling of patient's room within 24 to 48 hours of decontamination to show that cross-transmission occurs from the patient to the environment (and not visa versa). E. Perform environmental cultures of patient's room once per week until discharge from the ICU to determine the rate of environmental contamination with A. baumannii. F. Sample multiple environmental surfaces (Aims 2C, 2E) to determine which are most commonly colonized. G. Perform molecular typing on a sample of patient clinical cultures and environmental cultures to determine genetic relatedness between patient and environmental isolates. H. Compare the frequency of environmental contamination among persons with High Burden of Organism to those with Low Burden of Organism to determine if a greater organism burden is more likely to result in environmental contamination and to determine if a particular patient site (e.g. peri-rectal, respiratory, wound, skin) is more likely to lead to environmental contamination. Specific Aim 3: To estimate the risk of acquisition of A. baumannii from occupying a room that immediately previously held a patients with A. baumannii colonization or infection in a retrospective cohort of approximately 10,000 ICU patients constructed in Aim 1 Hypothesis 3: Occupying a room which immediately previously housed patients colonized or infected with A. baumannii is associated with a higher risk of A. baumannii acquisition. Specific Aims 3 - Steps: A. Exclude from Aim 1 cohort, patients who are colonized or infected with A. baumannii at ICU admission. B. Using the central data repository and the data collected in Aim 1; identify patients in which the prior occupant of their hospital room had a positive clinical or surveillance culture for A. baumannii (i.e. exposed group) and patients in which the prior occupant of their hospital room DID NOT have a positive clinical or surveillance culture for A. baumannii (i.e. unexposed group). C. Identify patients who acquire A. baumannii colonization or infection during their ICU stay for both the exposed and unexposed group defined in B. D. Compare acquisition rates of A. baumannii colonization and infection among the exposed and unexposed group while controlling for potential confounders such as time at risk, age, severity of illness and comorbid disease.